FREQUENCY NURSES ENGAGE IN END-OF-LIFE DISCUSSIONS W/PATIENTS AND THE BARRIERS

Questionnaire was designed by the investigators and assistance of a faculty advisor and statisticians at the GCRC. Two page questionnaire serves to describe nurses' basic knowledge of advance directives and the Patient Self-Determination Act, the frequency of discussions concerning end-of-life care, and perceived barriers to these discussions. The demographical information will be crossed with questions to target groups engaging in these discussions and those that are not.